Clinical Core - The Center for Innovation in Point-of-Care Technologies for HIV/AIDS and Emerging Infectious Diseases at Northwestern University (C-THAN)

SUMMARY – CLINICAL CORE
The Center for Innovation in Point-of-Care Technologies for HIV/AIDS and Emerging Infectious
Diseases at Northwestern University (C-THAN) will continue to be a vital partner in the NIBIB Point-of-Care
Technologies Research Network (POCTRN) of Technology Research and Development Centers (TRDCs).
The C-THAN Clinical Core will benefit from many years of infectious diseases-focused research and training
with clinical sites in Nigeria, South Africa, Mali, Senegal, and Tanzania. In addition to our key academic
partners, we will integrate many other international, national, regional and community stakeholders involved in
POC and home-based technology development across the partner institutions. Our overarching objective is to
develop a pipeline of POC and home-based technologies that meet the clinical needs of individuals with
HIV/AIDS and emerging infectious diseases (EID) in low and middle-income countries (LMICs). Investigators
will be required to demonstrate analytical and clinical performance of technologies as well as usability in low
resource settings. The Clinical Core specific aims are: 1. validate and establish protocols for innovative POC
and home-based technologies developed for the diagnosis and management of HIV/AIDS, HIV-related co-
morbidities, and EID in “real-world” clinical or community settings. 2. assess clinical user (caregiver and
patient) perceptions of device usefulness, acceptability within the sociocultural context, friendliness, and
comfort of HIV/AIDS and EID POC and home-based technologies, and 3. support translation of innovative
POC and home-based technologies from the Development Core into clinical studies though pilot funding,
expertise in clinical validation study design, and providing services including biospecimens with clinical data.
Our Clinical Core will continue to provide a “clinical laboratory” for innovators that will focus on validation and
user assessment of POC and home-based diagnostics on HIV/AIDS and EID. Depending on the status of a
developing POC technology, we will work across Cores to select projects to participate in either the Clinical
Core or Technology Core. The primary goal of the Clinical Core is to provide infrastructure and services
dedicated to clinical validation (from stored samples or clinical studies) and to evaluate clinical user
acceptability to ensure that the POC technology prototypes supported under this program have a high rate of
success for clinical uptake and maximal public health impact.